Molecular and Cellular Alcohol Research Training

The Bowles Center for Alcohol Studies (BCAS) training program at the University of North
Carolina at Chapel Hill is designed to promote the development of promising postdoctoral
research fellows as independent investigators and future University faculty members who will
investigate the pathogenesis of alcoholism and alcohol abuse using modern molecular, genetic,
biochemical and imaging techniques. Training of the postdoctoral fellows will be individualized
with the most important component being the research conducted by the trainee in the faculty
mentor's laboratory. In addition to hands-on alcohol research, training will include seminars and
conferences, activities on responsible conduct of research, professional development, didactic
courses, and other training as needed to prepare fellows for independent research. The training
faculty will consist of 14 funded investigators from multiple departments at the University of
North Carolina at Chapel Hill. The faculty has a documented history of close interaction and
collaboration. The trainees will benefit from the unique strengths of alcohol research at the
University of North Carolina BCAS, which include the NIAAA-funded Alcohol Research Center
with its research cores, the UNC Neuroscience Center, and the North Carolina Translational
and Clinical Sciences Institute (NIH-funded Clinical and Translational Science Award). The
training program will be led by Co-Directors, Drs. Fulton Crews, Donita Robinson and Thomas
Kash, with the assistance of two senior alcohol researchers, Drs. Clyde Hodge and Leslie
Morrow, who will constitute the Training Program Advisory Committee. The External Advisory
Committee provides another level of oversight. The program proposes seven post-doctoral
fellow slots. Trainees will receive two years of research training with the possibility of a third
year and with external support sought for later years. This institutional training grant has a
strong track record and will promote intensive training in molecular, biochemical and imaging
techniques and basic pathophysiology in a stimulating environment, leading to broadly trained
independent investigators capable of adapting to the rapid advances in research in the 21st
century.

Public health relevance
The goal of this Grant is to train new alcohol research scientists. Training scientists in alcohol research methods is essential to understanding the complex nature of binge drinking and alcohol use disorder. Multi-disciplinary training in molecular mechanisms of alcoholic pathology will cover fetal, brain, genetic, behavioral and other pathologies involved in long term drinking.